IGF::OT::IGF Resource Center Clearinghouse AD Education Referral Center

The title of the contract is “NIA Information Resource Center Clearinghouse and The Alzheimer’s Disease Education and Referral Center (ADEAR) ? The purpose of the contract to “Provide for the operation of the NIA Information Center and The Alzheimer’s Disease Education and Referral Center (ADEAR)?and support the Women of Color Research Network Hosting and Maintenance and BLSA Website Development and Implementation.